Mechanisms and function of the microtubule podosome connection in osteoclasts

DESCRIPTION (provided by applicant): Increased osteoclastic resorption is responsible for multiple bone diseases, whether systemic (osteoporosis, Paget's disease, hyper-parathyroidism for instance) or local (rheumatoid arthritis, periodontal disease, multiple myeloma, tumor osteolysis etc.). Despite the existence of several anti- resorptive drugs, evidence of unwanted effects is emerging. It therefore remains of the utmost clinical importance to better understand the biology of the osteoclast (OC) and of bone resorption. Our laboratory has been heavily invested in the detailed molecular understanding of OC biology and bone resorption. One of the most salient features of this work, supported by many other laboratories, is the demonstration of the critical importance of the attachment of the OC to bone, mediated by a specialized adhesion structure, the actin-containing podosome, which in OCs is specifically organized in a peripheral belt (the actin ring) and ultimately in a sealing zone when OCs are on bone and actively resorbing. The formation of a podosome belt is an OC-specific feature. An important breakthrough has been the demonstration of the critical role played by microtubules (MTs) in the organization of podosomes into an actin ring and a sealing zone and consequently in bone resorption (Destaing et al. 2004; Gil-Henn et al., 2007; Purev et al., 2009). The primary goal of this application is to further elucidate the molecular mechanisms by which MTs are connected to and regulate the podosomes, and in particular the transition from clusters to a peripheral belt, and bone resorption. Our preliminary data revealed a functional interaction between MTs, the +Tip protein EB1, cortactin and podosomes, required for the formation of podosome belts. Our proposal focuses on the molecular regulation of the + ends of MTs and of their interaction with actin and actin-regulating proteins in podosomes in OCs. This will help understand the mechanisms that regulate the localization and turnover of podosomes and their organization in a peripheral belt, an OC-specific and necessary step in the establishment of the sealing zone, itself required for bone resorption. We propose to: 1- Determine the role of the +TIPs protein EB1 in linking MTs to actin dynamics in podosomes. 2- Determine the role of cortactin (and its close homolog HS1) and its interaction with EB1 in the link between MTs and actin dynamics in podosomes. 3- Analyze the role of Src and HDAC6, i.e. Tyrosine phosphorylation and acetylation, in the link between MTs and actin dynamics in podosomes. The studies may open new therapeutic avenues to regulate bone resorption, with potential impact on the treatment of osteoporosis, osteolytic diseases and also cancer, given the similarities between podosomes and invadopodia.

Public health relevance
PUBLIC HEALTH RELEVANCE: Increased osteoclastic resorption is responsible for multiple bone diseases, whether systemic (osteoporosis, Paget's disease, hyper-parathyroidism for instance) or local (rheumatoid arthritis, periodontal disease, multiple myeloma, primary or metastatic tumor osteolysis etc.). The primary goal of this application is to further elucidate the molecular mechanisms by which osteoclast attach to and resorb bone to better understand the biology of the osteoclast and of bone resorption to design new and safer drugs. __SpecificAimsTextDelimiter__ 1) SPECIFIC AIMS: Increased osteoclastic resorption is responsible for multiple bone diseases, whether systemic (osteoporosis, Paget's disease, hyper-parathyroidism) or local (rheumatoid arthritis, periodontal disease, multiple myeloma, tumor osteolysis etc.). Despite the existence of several anti-resorptive drugs on the market, evidence of unwanted effects is emerging in multiple circumstances such as osteonecrosis of the jaw (ONJ) or atypical sub-trochanteric femoral fractures. It therefore remains of the utmost clinical importance to better understand the cell and molecular biology of the osteoclast and of bone resorption and its role in bone remodeling in order to design better targeted therapeutic intervention, ideally impairing the function of the osteoclast without interfering with bone formation and bone quality. It is in this context that our laboratory has been heavily invested in the detailed molecular understanding of osteoclast (OC) biology and the process of bone resorption for many years. After being the first group to demonstrate that OCs are molecularly polarized to transport protons and to acidify the bone- resorbing compartment (1), we also demonstrated targeted polarized secretion of lysosomal enzymes (2) and the importance of tyrosine kinase signaling from integrins, involving Src (3-6), Cbl (4, 7), dynamin (8, 9), and Pyk2 (5, 10, 11). One of the most salient features of this work, strongly supported by the work of many other laboratories is the demonstration of the critical importance of the attachment of the osteoclast to the bone surface for its migration, polarity and functional isolation of the bone-resorbing compartment. These functions are all mediated by a specialized and characteristic adhesion structure, the actin-containing podosomes and its organization in a peripheral belt (the actin ring) and ultimately the formation of a sealing zone when OCs are on bone surfaces and functional. An important breakthrough from Dr Jurdic's group and from our laboratory in the last few years has been the demonstration of the critical role played by microtubules in the patterning of podosomes into an actin ring and a sealing zone, structures that are unique to OCs and essential for bone resorption (10, 12, 13). The primary goal of this application is to further elucidate the molecular mechanisms by which microtubules are connected to and regulate podosomes and their patterning into a sealing zone, and thereby bone resorption. This grant proposal is centered on a well defined and testable hypothesis, focused on a regulatory axis containing three key proteins (EB1-CTTN-cofilin) linking MTs to actin filaments in podosomes and allowing formation of actin rings. It is strongly supported by our recently published results (10, 13), by the literature (see Background) and by our preliminary data. Hypothesis (see Fig 13): In osteoclasts, the dynamics and patterning of podosomes, leading to the formation of the sealing zone, a structure unique to OCs is controlled in part by MT plus-ends, through the tubulin-EB1-CTTN-cofilin-actin pathway. This pathway is regulated by tyrosine phosphorylation and deacetylation of these proteins, by Src and HDAC6, respectively. The information from these interactions flow in both directions, affecting both tubulin upstream and actin dynamics downstream, i.e. MTs and podosomes. This regulatory axis is essential for the functional organization of OCs and thereby bone resorption. Having established that MTs are essential regulators of the dynamics of podosomes and in particular the transition from cluster to podosome belt and sealing zone, we propose to 1- Determine the role of the +TIP protein EB1 in linking MTs to actin dynamics in podosomes 2- Determine the role of CTTN (and its close homolog HS1) and its interaction with EB1 in the link between MTs and actin dynamics in podosomes. 3- Analyze the role of Src and HDAC6, i.e. tyrosine phosphorylation and acetylation, in the post- translational modifications of tubulin, EB1, CTTN and cofilin and their role in the link between MTs and actin dynamics in podosomes. The studies proposed in this application are innovative, since few published studies focused on the role of MTs in osteoclast biology and bone resorption, and significant because they explore an essential and specific feature of the osteoclast, i.e. not only the formation of podosomes but their arrangement in a belt and sealing zone, potentially opening new therapeutic avenues to regulate bone resorption, with potential impact on the treatment of osteoporosis, periodontal disease, multiple myeloma, tumor osteolysis and also other cancers, given the similarities between podosomes and invadopodia.